Telemetric Regenerative Bandage for Accelerating Wound Healing

Summary
Diabetic foot ulcers (DFUs) are a major complication of diabetes. These sores, if left untreated, can become
infected and become a serious threat to the patient’s well being. Although the field of wound care management
is well established, the effective treatment of chronic DFUs remains a challenge. The primary goal in the
treatment of DFUs is for the wound to close as soon as possible and to do so in a durable way. However,
prolonged inflammation, oxidative tissue damage, and impaired blood circulation in diabetic wounds delay the
wound healing process, resulting in open, non-healing wounds that often lead to limb amputations. This proposal
will address these problems by developing a versatile wound dressing that restores normal wound healing rates
by reducing free radicals in the wound, providing a native-like scaffold for the cells to divide and migrate, and
enhancing vascularization in the wound. Another problem is the inability to monitor the wound in real time after
the patient leaves the hospital, leading to digit or limb amputations. We will address this problem by developing
a wireless system that can monitor the temperature and pH of the wound in real time, parameters that have been
shown to be indicators of infection. Therefore, the overall goal of this proposal is to develop a shape-
conforming antioxidant dressing that upon exposure to body temperature transforms into a gel that
promotes new tissue formation in diabetic wounds and a feedback system that involves tissue
conforming sensors to monitor bacterial infection and/or lack of healing. Toward this goal, we have
developed a novel macromolecule - poly (polyethylene glycol citrate-co-N isopropyl acrylamide) - that
incorporates a laminin-derived peptide. This material, referred to as PPCN-A5G81, supports tissue regeneration
and can conform to the unique shape and depth of a wound. As for wireless monitoring of the wound, we
pioneered the development of flexible, stretchable electronic sensors that can be integrated with human skin or
implanted into the body for continuous, non-invasive health monitoring and treatment of disease. We hypothesize
that: 1) incorporating immobilized Cu2+ into PPCN-A5G81 will confer vasculoinductive properties that significantly
increase PPCN-A5G81’s ability to restore normal healing rates of full thickness dermal wounds in diabetic mouse
and swine models; and 2) conforming temperature and pH sensors are safe and can remotely provide real time
information regarding blood perfusion and infection in dermal wounds in diabetic animals. The specific aims of
this proposal are to: 1) fabricate a PPCN-based regenerative dressing with vasculoinductive, dermoconductive,
and dermoinductive properties and investigate its safety and efficacy for healing full thickness wounds in diabetic
mice and diabetic pigs with metabolic syndrome; and 2) fabricate and characterize telemetric wound feedback
tissue-conforming sensors capable of measuring temperature and pH in infected and non-infected diabetic
dermal wounds. Results from this research will contribute to the development of innovative clinical products that
reduce amputation rates and improve patient outcome.

Public health relevance
Telemetric Regenerative Bandage for Accelerating Wound Healing Narrative This project describes the development of a shape-conforming antioxidant dressing that upon exposure to body temperature transforms into a vasculoinductive, dermoconductive and dermoinductive scaffold that promotes new tissue formation in diabetic wounds. It also involves developing a wireless wound feedback system that involves tissue conforming temperature and pH microsensors to monitor potential bacterial infection and/or lack of healing to improve patient outcome.